IMAGING OF SYNAPTIC VESICLES &CALCIUM LEVELS OF STIMULATED HIPPOCAMPAL NEURONS

Dissociated neurons from rat hippocampus are often used to study the kinetics of neural transmission due to their ability to form connections and plasticity. We have developed a protocol using a variety of established methods for the growth and maintenance of hippocampal neurons from 1-5 day old rats. These neurons were imaged using widefield and confocal microscopy. The following features were investigated: a) internal calcium after loading with the AM dye fluo-3. Responses to potassium and glutamate stimulation were observed; b) synaptic vesicle staining using styryl dye FM1-43. Again, responses to potassium and glutamate stimulation were observed; c) synaptic vesicle staining of fixed cells using synapsin I (a protein found at synaptic terminals)- antibody; d) labeling of NADH receptors after loading with conatotoxin; e) testing general microinjection capabilities with FM1-43 and fluorescein-labeled dextran.